Diversity-focused Montefiore Einstein Clinical Oncology Training Program in the Bronx

Project Abstract
The goal of Einstein/Montefiore Paul Calabresi Career Development Award for Clinical Oncology and Equity
Research is to train the next generation of oncology scholars, with a special emphasis on conducting clinical and
translational research in the underserved and diverse Bronx catchment area. This will be achieved through a
coordinated program of mentoring, a comprehensive formal curriculum, and research projects with an
interdisciplinary, collaborative design with focus on community outreach and engagement. The program, its
leadership and participants are integrated within the established research programs of the NCI-designated
Montefiore Einstein Cancer Center (AECC). The Calabresi Program will select highly qualified clinical and
translational investigators from all oncology disciplines, from a diverse group of primarily MDs, but also PhDs,
who are committed to careers in patient-oriented clinical and translational research with a focus on diverse
populations. The duration of the training is 2 to 3 years and funding for 4 scholars is requested. The research
focus is being expanded beyond cancer therapeutics to include cancer care delivery relevant to the Bronx
population, which is 70% URM’s. A formal curriculum has been developed in conjunction with Einstein’s Institute
for Clinical and Translational Research (ICTR) featuring an MS degree in Clinical Research Methods and
includes two mandatory Calabresi-centered courses, one on “Clinical Trial Development in the Era of
Personalized Cancer Medicine and Immunotherapy”, and another on “Comparative Effectiveness Therapeutic
Research”. Additional courses and workshops are offered in Biostatistics and Grant writing. The Principal
Investigators are Dr. Amit Verma, M.D., Director of the Division of Hemato-Oncology, and Dr. Yvonne Saenger,
MD, Director of the Immunotherapy program and Coleader of Experimental Therapeutics. Both PIs bring
complementary expertise in both liquid and solid tumors and also a track-recordin basic/translational and clinical
research, as well as in mentoring junior clinical investigators. An Executive Committee of senior faculty leaders
provide oversight in the selection and ongoing evaluation of the progress of the Scholars and the impact of the
program. An Internal Advisory Board (IAB) chaired by cancer center director, Dr. Edward Chu, and an External
Advisory Board with K12 PIs will provide guidance and direction to the Calabresi program. Novel initiatives are
planned to increase the recruitment of URM candidates. Strong institutional support from the Medical College,
Cancer Center and Montefiorehas resultedin salary support of numerous scholars. Since inception, the Program
has enrolled 24 Scholars (3 URMs): with 22 remaining committed to academic careers in leadership positions in
oncology. A successful track record of high impact publications, especially in fields of minority outcomes in
diverse populations of the Bronx is evidence of uniqueness of the proposed training program. Our proposed K12
training grant will train the next generation of oncology clinical researchers on unique challenges of conducting
successful clinical trials in underserved minority populations, using the Bronx as a model ecosystem.

Public health relevance
Project Narrative The objective of this program is to train clinical and translational physician-scientists to develop new cancer treatments and improve cancer care delivery at the Montefiore Einstein cancer center. This will be achieved through a coordinated program of mentoring, innovative didactic courses, and emphasis on diversity based equity care delivery for underserved population via an interdisciplinary collaborative design.